RETINAL POSITION AND OBJECT CATEGORY EFFECTS IN THE HUMAN LOC

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. INTRODUCTION One of the most fundamental aspects of human cognition is our ability to recognize familiar objects rObject-selective regions of human cortex, including the lateral occipital complex (LOC), are known to be sensitive to the retinotopic position of object stimuli and to object category. However, there has been little quantitative measure of the extent, organization or relative magnitude of these effects.